Generation and characterization of a humanized mouse model of Crohn's disease

Generation and characterization of a humanized mouse model of Crohn’s disease
Crohn’s-disease (CD) and ulcerative colitis (UC) are the two major forms of inflammatory bowel disease
(IBD), a chronic inflammatory disorder that affects an estimated 3 million Americans. The etiopathogenesis
of CD is distinctive for each patient and involves a complex interaction between genetic factors, the immune
system, the gut microbiota and other environmental factors. Mouse models of IBD have been invaluable in
providing critical mechanistic insights into its complex etiopathogenesis and in indicating new potential
therapeutic targets. However, it has been particularly difficult to translate advances in our understanding of
IBD pathogenesis into novel therapies that prove successful in the clinic. A major obstacle is that mice and
humans, despite their similarities, have fundamental differences in their intestinal physiology and, crucially,
in the function of their immune system. A second problem is that the vast majority of mouse models of IBD
recapitulate aspects of the natural history of UC but not the unique pathology of CD. Not surprisingly,
notable examples of clinical trials that failed in CD patients were originally guided by mouse models of colitis
at the preclinical level. One inviting avenue for pre-clinical testing is humanized mouse modeling, where
human hematopoietic stem cells (HSCs) are engrafted into immunodeficient mice and a human immune
system develops in the mouse host. Humanized mouse models allow to study the function of human
immune cells in vivo without directly involving human patients. Despite recent progress in the humanization
of the immune system in mice, the development of humanized models of IBD is lagging behind and has
been limited to the chemical induction of colitis upon transfer of human CD4+ T-cells. Translational animal
models that faithfully recapitulate human CD pathology have been lacking. In this project we aim to develop
the first humanized mouse model of CD. For this purpose we will integrate two state-of-the-art mouse
models: a genetic mouse model that specifically resembles the pathological and mechanistic features of
human CD and the MISTRG6 humanized model which supports the most comprehensive humanization of
the immune system achieved to date, including not only T, B and NK cells, but also myeloid populations
crucial in CD such as macrophages and neutrophils. Major goals of this pilot project are to 1) generate
these mice by CRISPR/Cas9 engineering and optimize the humanization of their immune system and 2)
determine the kinetics of humanized Crohn’s pathogenesis and thoroughly characterize its phenotypic
aspects at the level of tissue pathology and intestinal immune responses. This humanized system will be an
important and unique preclinical/translational tool for the CD research community. It will reveal pathways
employed by human immune cells to drive CD pathogenesis and also enable future studies assessing the
effectiveness of candidate therapeutics against human targets as well as studies aiming to uncover the
specific effect of human genetic variants associated with CD on the function of a human immune system.

Public health relevance
Project narrative Crohn's disease (CD) is a major form of inflammatory bowel disease that affects millions of Americans, however, the development of novel therapeutics for this disorder remains challenging, because of the lack of specific preclinical tools recapitulating its complex immune responses and its distinct pathological features. In this project we aim to develop the first humanized mouse model of CD by engineering mice that develop a chronic CD pathology driven by a human immune system including human T-cells, B-cells, NK cells, macrophages and neutrophils. This mouse model will be a unique tool not only for basic and translational discovery but also for preclinical testing of candidate therapeutics for CD directly in human immune cells in vivo.